Evaluation of Immunodominant fragments of PfGARP for malaria vaccine development

Project Summary
Malaria affects almost half the world’s population and causes more than half a million deaths
annually. Children with underdeveloped immune systems in malaria-endemic areas have the
highest mortality rate but no vaccine candidates are explicitly identified for this group. Global
efforts to control the disease have had limited success, with no blood-stage vaccine being
approved yet. However, the WHO recommends two sporozoite protein-based vaccines, RTS,
S/AS01, and R21/Matrix-M, for human use but achieving broad implementation and evaluation
of global efficacy remains a challenge. Therefore, there is an urgent unmet need to discover
new vaccine candidates or improve the efficacy of known antigens to develop a new generation
of malaria vaccines for children. Previous studies in our lab identified a novel vaccine candidate,
PfGARP, using phase display screening of malaria-resistant children's serum and P. falciparum
T7 Phage-based cDNA library. Our work has culminated in the discovery of Pf Glutamic Acid
Rich Protein A (PfGARP-A) and a comprehensive, full-length Research Article in Raj et al.
Nature, 2020. During the screening phase of our approach, we identified antigens from C-
terminus regions of PfGARP overlapping with each other and interacting only with the
antibodies from the plasma of malaria-resistant children. The above findings indicate that the
lower molecular weight recombinant PfGARP (rPfGARP) antigens might have the crucial
domain for functional antibodies and can generate growth inhibition activity comparable to
PfGARP-A. In our preliminary approach, we immunized the mice (n=5/antigen) with DNA
vaccine using the smaller fragments of the immunodominant regions as PfGARP-B, PfGARP-C,
PfGARP-D, and a 324 bp N-terminus fragment of PfGARP (PfGARP-E as negative control) and
harvested polyclonal serum. Our preliminary data demonstrate that polyclonal serum generated
against PfGARP-B and PfGARP-C in mice specifically interacts with P. falciparum in western
blot, flow cytometry, Immunofluroscent microscopy, and shows significant parasite-killing activity
in growth inhibition assay (GIA) comparable to PfGARP-A. The study aims to develop human-
usable recombinant protein and LNP-mRNA-based platforms for PfGARP-B & C antigens using
in vitro assays and humanized murine model (in vivo) against P. falciparum, the deadly human
malaria parasite. These studies will form the core supporting data for further development of the
lower molecular weight rPfGARP antigens, which could help reduce the production cost and
make it easier to use with other blood stage proteins as fusion antigens with the ultimate goal of
an efficacious malaria vaccine for humans that has better efficacy against children.

Public health relevance
Project Narrative Malaria, the deadliest parasitic disease on the planet, has eluded vaccine development for over a century. Our vaccine discovery effort using antibodies from plasma of malaria-resistant children identified PfGARP, a previously unrecognized vaccine candidate unique to P. falciparum (Nature, 2020). The primary objective of the proposal is to conduct a thorough evaluation of the overlapping immunodominant regions of PfGARP antigens on both the recombinant protein and mRNA-LNP platforms, which will be carried out using in vitro assays and humanized mice models (in vivo) with an ultimate goal of developing an effective malaria vaccine for human use.